Air Pollution, Metabolome, and Alzheimer disease in Mexican Americans

PROJECT ABSTRACT
Air pollution is increasingly recognized as an important risk factor for cognitive impairment (CI) and Alzheimer’s
and related dementias (ADRD). To gain insights into the biologic processes which link air pollution exposure and
ADRD in humans during aging, we propose an integrative longitudinal metabolomics approach in a large
population-based cohort of Mexican-Americans relying on real-life, long-term air pollution exposures for which
we established links with ADRD. Metabolomics can provide a map of exposure and disease-related perturbations
across interconnected biological pathways. It is especially useful in gaining understanding of disease processes
when repeated biosamples are available before diagnosis to provide novel information about initiation and
progression of cognitive impairment and ADRD. Specifically, we propose to use untargeted and targeted
metabolomics to further mechanistic understanding of long-term exposures to air pollution and CI/ADRD in an
elderly population of Mexican Americans from the “Sacramento Area Latino Study on Aging” (SALSA), taking
advantage of 5689 existing blood samples from 1,789 Latino participants followed over 10 years, screened for
cognitive function (7,696 repeated cognitive exams), and tested with multi-domain neuro-psychological batteries,
clinical and MRI assessments for dementia adjudication. Latino minority populations suffer disparities in
exposures and a high prevalence of comorbid risk factors, such as diabetes. We have already observed strong
associations for air pollution exposure with incident ADRD. Previously, we conducted an air monitoring campaign
and combined this with routine monitoring data, land use, emissions, traffic data, and meteorology to generate
air pollution exposures for SALSA participants (R01ES023451 mPIs: Ritz/Haan). Here, we will collaborate with
Dr. Jones at Emory who directs a Center that developed cutting edge high-performance metabolic profiling
methods. We will employ these unique resources to identify molecular mechanisms of air pollution and CI/ADRD
in Latinos longitudinally, to show how the metabolome is changing as cognition declines and CI/ADRD develops,
how air pollution exposure changes the metabolome over follow-up, and how vulnerability or resilience
contributes to the process of developing dementia. We will also evaluate the influence of air pollution on
intermediate biomarkers previously linked to CI/ADRD, including inflammatory, metabolic, and antioxidant
markers (TNF-a, IL6, CRP etc.). Finally, we will study how known ADRD risk factors such as APOE4, diabetes,
physical activity, or gender affect air pollution related metabolomic profiles using repeated measures and multi-
level clustering to generate insight into the multifactorial etiologies of CI/ADRD. We also propose to conduct
replication analyses using existing metabolomics from the same platform, air pollution and cognitive assessment
data in 277 elderly Central Californians. This study will improve our understanding of mechanisms of air pollution
toxicity related to CI/ADRD, such pathways may provide actionable and treatable targets. It will also help find
evidence-based biomarkers for those most at risk and support causality and suggest mitigation approaches.

Public health relevance
PROJECT NARRATIVE The goal of this research is to use a metabolomics approach to find biomarkers for air pollution toxicity and physiologic responses among people who do or do not develop cognitive impairment and Alzheimer’s or related dementias (ADRD). This research will help us understand better the mechanisms and responses of biologic systems to air pollution exposures that contribute to degeneration of the aging brain and inspire prevention efforts. To accomplish this, we will newly generate metabolomic information in thousands of plasma samples taken repeatedly from the participants in the “Sacramento Area Latino Study on Aging” (SALSA) study of elderly Mexican Americans linking these to exposures and ADRD outcomes.